Bridges to the Doctorate at Towson University

PROJECT SUMMARY/ABSTRACT
African-American/Black, Indigenous, and Hispanic are among the fastest growing populations in the US but
make up only a small percentage of the biomedical research workforce. This disconnect is particularly acute in
science and engineering graduate programs where students from underrepresented (UR) groups accounted for
just 13.5% of doctoral degrees awarded in 2018. Furthermore, significantly more students from UR groups
complete a master’s degree (MS) en route to their doctorate than their non-UR counterparts, identifying MS
programs as an important pool from which to recruit PhD candidates from diverse backgrounds. Consistent with
these national trends, self-assessments at the University of Maryland School of Medicine (UMSOM) and Johns
Hopkins University School of Medicine (JHUSOM) revealed that just 13% and 17% of doctoral degrees awarded
over the past five years were to students from UR groups. In just five years, the Bridges to the Doctorate Program
(B2D) program has had a significant impact on the diversity of the MS program in Biological Sciences at Towson
University (TU), increasing the representation of students from UR groups from 11% in 2015 to 42% in 2020,
mirroring the local demographics (45.3%). 100% of our B2D trainees have graduated with an MS degree. Of
the trainees who have graduated, 67% have applied to PhD programs and 83% of those who applied,
were offered admission to top doctoral programs including those at UMSOM and JHUSOM. These data
highlight the need for programs like B2D that support students from UR groups as they prepare to apply to
doctoral programs and succeed in transitioning from MS to PhD programs to complete their doctorate. The TU-
UMSOM-JHUSOM B2D will integrate the TU MS program and research resources at the UMSOM and JHUSOM
in an innovative curriculum of training and mentoring to meet the following four objectives. 1: To provide
trainees with a strong knowledge base in cell and molecular biology, develop analytical thinking, and
cultivate science self-efficacy. 2: To train students to independently design and conduct experiments with rigor
and to effectively analyze results. 3: To provide trainees with the tools needed to successfully apply to doctoral
programs and ultimately earn a PhD. 4: To foster an inclusive, supportive community that promotes student
success by providing opportunities for career exploration and peer/professional mentoring. The proximity of TU,
UMSOM, and JHUSOM campuses facilitate the collaborative implementation of joint training activities. B2D
scholars will be actively recruited from local and national minority-focused training programs and undergraduate
institutions through e-marketing, social media, and in-person approaches. The professional development of B2D
trainees as they progress from MS to PhD programs and beyond will be tracked as an important metric of
program success. All aspects of the B2D will be critically evaluated by systematic program assessment. B2D
training will thus enhance diversity in the biomedical workforce.

Public health relevance
NARRATIVE In light of the positive impact of workforce diversity on innovation in biomedical research and addressing public health, achieving a biomedical workforce that reflects the increasing diversity of the US population is essential to meet growing science and technology demands; however, individuals from underrepresented groups comprise a small percentage of the doctoral level biomedical workforce. Towards the goal of increasing workforce diversity, the Bridges to the Doctorate (B2D) partnership between Towson University (TU), the University of Maryland School of Medicine (UMSOM), and Johns Hopkins School of Medicine (JHUSOM) will create a supportive minority-focused training program in which students gain critical research and professional experience while completing their Master’s degree at TU. The TU-UMSOM-JHUSOM B2D training program will prepare students for the successful transition from MS to PhD programs and completion of the doctorate at UMSOM, JHUSOM, and other institutions nationwide, thus increasing representation in the biomedical profession and enhancing diversity in this workforce.